HIGH SCHOOL HONORS RESEARCH PROGRAM

The High School Internship Research Program of the Old Westbury Neuroscience Research Institute is designed to increase the number of minority students entering neuroscience/mental health undergraduate programs. The college at Old Westbury is ideally suited to carry out this mission, since it has faculty whose research focus in cellular and molecular neuroscience, and behavior has obtained professional recognition, and relates very well to NIMH interests. The faculty is multiethnic in composition, with also a high percentage of minority students who choose science as a major (65 percent) -- all of whom can be inspiring role models. The faculty interests help to generate relevant students projects at the molecular organismic, and behavioral levels; for example, our major research projects focus on HIV, opiates as neurotransmitters, and nitric oxide involvement in neuroprocessing. A similar high school internship research program has been successfully operating as a supplement to the COR undergraduate training grant. It has already produced Westinghouse semifinalists and competitive research projects. The program benefits from interaction with other college programs, and has already established a solid reputation with area high schools. It extends through the academic year and the summer, and consists of (a) developmental and (b) research components, the latter working in the laboratories of preceptors through the gamut of investigative phases, from proposition to experimentation and conclusion. The facilities and state-of-the-art equipment provide the ideal setting for the learning of advanced laboratory techniques -- a rare opportunity for high school students.